Understanding the role of Ric-8 in Ga 12/13 signaling

DESCRIPTION (provided by applicant): Heterotrimeric G proteins are important bi-molecular switches that transmit signals from a diverse array of membrane receptors for neurotransmitters, hormones and extracellular morphogens to activate downstream intracellular signaling pathways. Members of the Gα12/13 family are particularly important during embryonic development as they are essential for the development of the circulatory system and are required for embryonic angiogenesis. The goal of this proposal is to understand how Ric-8 participates in signaling in the Gα12/13 pathway. We will use the Drosophila gastrulation pathway as a model system to study Ric-8 to take advantage of the powerful cell biological tools and rich understanding of the Gα12/13 signaling pathway in flies. In this proposal we will 1) Conduct a structure-function study of Ric-8 within the context of Gα12/13 signaling; and 2) Identify novel proteins that are required for regulating Ric-8 activity in Drosophila. Given the hih degree of conservation of these pathways between flies and humans, these studies will provide understanding of the regulation of Gα12/13 protein signaling during vascular development and will identify novel molecules with potential therapeutic importance in the regulation of angiogenesis.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research is relevant to public health as it will advance our understanding of the signaling pathways involved in development of the circulatory system. These pathway play a key role in angiogenesis and understanding them at molecular detail will allow development of novel therapies that promote formation of blood vessels after injury or block angiogenesis during the tumorigenesis.